Acquisition of an iLas2 TIRF/FRAP imaging platform

Project Abstract. Signaling pathways that control cell movement and membrane morphodynamics are tightly
regulated at the subcellular level and occur with rapid kinetics. Therefore, the best way to investigate the
molecules involved in these processes is to observe and control them in real-time. To achieve this, we need to
develop molecular probes that report the activity of target molecules and microscopy systems to visualize and
control these probes in living cells. In the parent award, we propose to develop optogenetically controlled
inhibitors that modulate the activity of Guanine Exchange Factors of the Dbl family. These molecules are the
main activators of Rho family GTPases, the major regulators of cell membrane dynamics. In this supplement,
we request funds to acquire an iLas2 TIRF/FRAP imaging platform to characterize GEF-GTPases signaling in
real-time in living cells through the application of our engineered inhibitors. The iLas2 TIRF/FRAP system will
greatly enhance and expand the scientific premise of the parent awards by providing the ability to: 1) observe
biological events where they primarily occur, at the contact sites between the cell and the coverslip, due to the
TIRF capability; 2) rapidly uncage engineered inhibitors with accurate subcellular precision; 3) simultaneously
observe GTPase activity using fluorescent biosensors.

Public health relevance
Project Narrative. The activity of molecules that control normal biological processes that may become dysregulated and lead to disease is typically carried in discrete cellular regions. Direct observations of such molecules at the sites of their activity may provide insights into disease development and opportunities to develop treatments.